Center for dynamic RNA epitranscriptomes - Renewal

Project Summary/Abstract
Chemical modifications on mammalian messenger RNA (mRNA) have recently been shown to play critical and
diverse regulatory roles in mRNA metabolism and translation. For example, the most abundant mRNA
modification, N6-methyladenosine (m6A), is crucial for mammalian stem cell differentiation and tissue
development in almost all systems tested so far. Dedicated proteins, many of which are essential in mammals,
have evolved to install, recognize, and remove m6A marks (writers, readers, and erasers, respectively).
Dysregulation of m6A methylation has been connected to a variety of human diseases and disorders. Functional
roles have also been proposed for other internal modifications present in mammalian mRNA, including, but not
limited to: pseudouridine (Ψ), 5-methylcytosine (m5C), 2’-O-methylation (Nm), N1-methyladenosine (m1A), N7-
methylguanosine (m7G), and N3-methylcytosine (m3C). Our most recent research has uncovered modifications
on chromosome-associated regulatory RNAs (carRNAs), such as promoter-associated RNA (paRNA), enhancer
RNA (eRNA), and repeat RNAs, as well as frequent modifications in introns of pre-mRNA. The carRNA
modifications have been shown to regulate chromatin state and transcription, and intron modifications may affect
pre-mRNA processing. Despite rapid advances in the discovery and functional characterization of various RNA
modifications and their effector proteins, a significant bottleneck limits the entire field of epitranscriptomics
research: a dearth of quantitative sequencing methods that can comprehensively map most RNA modifications
at base resolution with exact modification fraction information. The availability of such methods is critical for
assessing the importance of these modifications in different regions of mRNA, examining the effects of dynamic
changes in modification fraction, assigning modifications to different writers and analyzing their functional
relevance, identifying target transcripts and sites of demethylation and analyzing their functional relevance,
discovering new effectors for RNA modifications by overlapping with known RBP-binding sites or genomics
features, and evaluating the physiological consequences of RNA modifications in biological processes. We have
established both nucleic acid chemistry and directed protein evolution platforms to invent new technologies that
transform RNA modifications to be read out as mutations or deletions that are universally compatible with extant
sequencing platforms. Computational pipelines and RNA modification databases will be built to support the new
method development and epitranscriptome research in the broad community. These new technologies will be
optimized to work on low-input samples, particularly neuronal and clinical samples. We will focus on integrating
new methods into robust protocols to map multiple RNA modifications in single experiments. Our proposed
research will deliver high-throughput, high-resolution, and high-sensitivity methods that simultaneously map
multiple RNA modifications in all biological areas.

Public health relevance
Project Narrative RNA modifications (collectively known as the epitranscriptome) play critical roles in both transcriptional and post-transcriptional gene expression regulation and broadly impact mammalian development and human diseases. The proposed research will develop high-throughput, high-resolution, and high-sensitivity methods to simultaneously map multiple RNA modifications for functional investigations of the epitranscriptome.